Assay Development and High Throughput Screening (ADHTS) Core

PROJECT SUMMARY/ABSTRACT Assay Development and High Throughput Screening Core (ADHTS)
The goal of the Assay Development and High Throughput Screening (ADHTS) Core of the Indiana University
School of Medicine Purdue University TaRget Enablement to Accelerate Therapy Development for Alzheimer's
Disease (IUSM-Purdue TREAT-AD) Center is to integrate sophisticated disease biology and drug discovery
capabilities and create Target Enabling Packages for the study of emerging Alzheimer's disease (AD)
hypotheses (beyond amyloid beta). Accomplishing this goal will create the foundation for new classes of
therapeutics to treat Alzheimer's disease. The supportive mission of the ADHTS Core is to advance target
validation and enable novel drug discovery opportunities for IUSM-Purdue TREAT-AD Center targets. In
collaboration with the other technical cores, we will use an integrated target assessment approach to improve
target validation and facilitate the selection of targets for enablement. This work supports the design and
development of individual assays and assembly into a connected set of in vitro and in vivo assays capable of
providing reliable data to support novel drug discovery. In addition, the ADHTS core will develop translational
biomarker strategies that support dose setting in early clinical development, thereby decreasing drug discovery
risk and providing a clear path to early clinical testing. Finally, the core will disseminate essential resources such
as novel reagents, assay methodologies, and data. All resources will be made available to the Alzheimer's
Disease research community through the Target Enabling Packages that are posted on the AD Knowledge Portal
and through direct requests made to the Center for transfer of materials. The ADHTS core directly contributes to
the success of the IUSM-Purdue TREAT-AD Center through delivery of target enablement packages for the next
generation of biological targets. The connected scheme of biochemical, cellular, and in vivo assays will be
capable of prosecuting robust Structure Activity Relationship studies with the intention of identifying clinical
candidates coupled with enabling biomarker assays positioned for translation to early clinical testing.